Cell autonomous and non-cell autonomous phenotypes due to genetic risk for late onset Alzheimers disease

Recent AD GWAS studies have uncovered a number of risk single nucleotide polymorphisms (SNPs) within genes predominantly expressed or upregulated in microglia in association with pathology suggesting that altered microglia function plays a critical role in disease etiology. Each of these polymorphisms can either confer increased or decreased risk and it will be important to understand how inheritance of each of these polymorphisms impact microglia function to modify disease risk. One identified AD GWAS risk SNP rs3865444 is near the CD33 gene, confers protection from AD, and is found in linkage disequilibrium with rs12459419 SNP, which leads to skipping of exon 2 that encodes the sialic acid-binding domain. CD33 is a member of the Sialic acid-binding immunoglobulin-like lectin (Siglecs) family of receptors in which sialic acid binding transmit signals from the extracellular microglial environment leading to downstream microglia signaling and a subsequent microglia cellular response/change. Because CD33 lacks a true murine ortholog, the study of CD33 requires human cells. The ability to generate microglia-like cells (iMGLs) from iPSC and development of microglia functional assays in my lab will enable investigation of the role of exon 2 skipping on microglia function. Patient and CD33 isogenic induced pluripotent stem cells (iPSCs) will be used to derive iMGLs to interrogate microglia function in the context of differing CD33 genotype. Using liposomal nanoparticles that bring together ligands of two receptors, we will examine the role of CD33 as a co-receptor in modulating Dap12 and FcRg signaling. In addition, we will investigate the functional significance of an interferon microglia signature uncovered by whole transcriptome analysis of patient-derived microglia-like cells. Lastly, a novel AD mouse model facilitating xenotransplantation will be employed to examine the CD33-D2 interferon signature in vivo and whether it improves behavior, reduces AD pathology, and therefore can be targeted as a novel AD therapeutic.

Public health relevance
This research study will investigate the mechanisms by which microglia dysfunction due to age and inheritance of genetic risk factors contribute to Alzheimer Disease, a devastating neurodegenerative condition that impairs memory and causes cognitive and psychiatric deficits. Because microglia play important roles in maintaining brain homeostasis and health, therapies aimed at restoring or enhancing their normal function may effectively mitigate disease course. This proposal aims to validate the role of the AD protective CD33 allele and elucidate the mechanism by which it regulates microglia homeostasis and can be targeted as novel AD therapeutic.